Hydrolysis-resistant resin networks for durable and multifunctional dental restorations

Summary:
The short average service life and the rising incidence of secondary caries currently hamper the reliability of
existing dental composite restorations. This underlines the pressing need for innovative, long-lasting dental
restorations composed of novel resin networks, multifunctional fillers and additives, and adhesive constituents.
Our goal is to create superior resins and resin composites for dental restorations. These new restorations will
surpass the capabilities of the extant methacrylate, ester-based analogs. Our strategy centers on formulating
and testing novel resins and resin composites that resist hydrolysis and enzymolysis and possess antimicrobial,
protein-repellent, and therapeutic attributes, consequently producing dental adhesives and resin composites with
performance and a lifespan exceeding their methacrylate-based equivalents currently being used in dental clinics.
We will achieve our goal in three Specific Aims. Aim 1: We will develop and evaluate biostable hybrid resin
networks that may withhold the harsh challenges in patients’ oral environments. By strategically alternating the
packing of the methacrylate units with hydrophobic styrene-derivative units, we will protect ester-groups from
hydrolysis, enzymolysis, and cariogenic bacteria attack. The novel biostable hybrid resin networks will
encompass an acidic component for self-etch dental adhesives and multifunctional components for various
needs in dental restorations. We'll then employ a highly sensitive method to quantitively assess and rank these
hybrid resins against traditional ester-based resins. Aim 2: We plan to formulate and develop new multifunctional
hybrid resins and resin composites. These materials should match or be better than their ester-based
counterparts regarding antimicrobial, protein-repellent, and therapeutic aspects. We hypothesize that these
hybrid resin networks can seamlessly integrate with the functional additives and fillers previously devised for
conventional ester-based dental resin networks. Aim 3: We will subject the newly developed resins and
composites to rigorous testing as restorations (combinations of dental adhesives and resin composites) on
extracted human teeth under static and cyclic loadings. We will confirm their long-term performance in the most
clinically relevant scenarios by simulating real-world challenges such as clinical aging, thermal cycling, and
cariogenic biofilm exposure. Successful completion of the proposed Aims will result in the production of
multifunctional, durable dental resin restorations adept at addressing various needs for treating dental cavities.

Public health relevance
Narratives: We will create new dental adhesives and composite materials by formulating an advanced resin network, incorporating therapeutic components and specialized additives that combat bacteria and minimize protein adherence. After conducting rigorous clinical-relevant assessments of the new materials on extracted human teeth, we aim to produce various advanced therapeutic solutions tailored to address various dental cavity challenges.